Maintenance and Enhancement of the Scope of ISO/IEC 17025 Accreditation for the Florida Department of Agriculture and Consumer Services Food Laboratories

The Florida Department of Agriculture and Consumer Services (FDACS), Division of Food Safety, Bureau of Food Laboratories achieved accreditation in 2007, and maintains A2LA accreditation to ISO/IEC 17025:2005 for the specific tests listed in A2LA certificates 2534.01 and 2534.02 (available at www.A2LA.org). The Division of Food Safety is responsible for assuring the public of a safe, wholesome and properly represented food supply through permitting and inspection of food establishments, inspection of food products, and performance of specialized laboratory analyses on a variety of food products sold or produced in the State. The Division monitors food from farm gate through processing and distribution to the retail point of purchase. The Division is charged with administration and enforcement of the food and poultry and egg laws, and also provides support in the enforcement of other food safety laws. In addition to regulatory surveillance and enforcement, the Division evaluates consumer complaints related to food. The Division has the responsibility for carrying out its duties or support functions as directed by the following Florida Statutes Chapters: 500, 501, 502, 503, 531, 583, 586, and 601. As the primary regulatory food testing laboratory for Florida the FDACS Food Laborartories work with our Department's Bureau of Food Inspection to conduct microbiological and chemical food analyses on behalf of the state’s manufactured food regulatory programs (MFRPS). These analyses are conducted within the scope of our ISO/IEC 17025 accreditation. The FDACS Bureau of Food Laboratories is applying for the cooperative agreement titled: ISO/IEC 17025:2005 Maintenance and Enhancement of ISO/IEC 17025 Accreditation for State Food Testing Laboratories, announcement number RFA-FD-17- 010, with anticipation of funding from 2017 through 2019 for maintaining accreditation and performing enhancements to the accredited laboratory system. The Food Laboratories has actively participated in the project titled Maintaining and Enhancing Accredtiation at the Florida Bureau of Food Laboratories under current grant number 5U18FD004474-05 continuosly since 2012. The FDACS Bureau of Food Laboratories is willing and able to participate in this opportunity, and is fully committed, to increase the analytical capacity of our nation's food testing regulatory laboratory under accreditation, increase our ability to share laboratory results to promote earlier identification and regulatory response to adulterants in the food supply, advancement of a nationally integrated food safety system, and thereby enhance efforts to protect the food supply and work toward ensuring the public's health. FDACS Food Laboratories are active participants in the FERN programs and are currently one of the FDA FERN CAP laboratories under grant number 1U18FD005506.

Public health relevance
The Florida Department of Agriculture and Consumer Services (FDACS), Division of Food Safety, Bureau of Food Laboratories achieved accreditation in 2007, and maintains A2LA accreditation to ISO/IEC 17025:2005 and the "AOAC International Guidelines for Laboratories Perfoming Microbiological and Chemical Analyses of Food, Dietary Supplements, and Pharmaceuticals" for the specific tests listed in A2LA certificates 2534.01 and 2534.02. The Division of Food Safety is responsible for assuring the public of a safe, wholesome and properly represented food supply through permitting and inspection of food establishments, inspection of food products, and performance of specialized laboratory analyses on a variety of food products sold or produced in the State. The Division monitors food from farm gate through processing and distribution to the retail point of purchase. As the primary regulatory food testing laboratory for Florida the FDACS Food Laborartories work with our Department's Bureau of Food Inspection to conduct microbiological and chemical food analyses on behalf of the state's manufactured food regulatory programs (MFRPS). These analyses are conducted within the scope of our ISO/IEC 17025 accreditation. In addition, the FDACS Bureau of Food Laboratories assists other State agencies such as the Florida Department of Health in the investigation of food borne illness through the testing of food products that are suspected in food borne illness outbreaks. The FDACS Food Laboratories are active participants in PulseNet and Genome Trackr and routinely submit subtyping data of pathogens isolated from food products. The FDACS Bureau of Food Laboratories is willing and able to participate in this opportunity, and is fully committed, to increase the analytical capacity of our nation's food testing regulatory laboratory under accreditation, increase our ability to share laboratory results to promote earlier identification and regulatory response to adulterants in the food supply, advancement of a nationally integrated food safety system, and thereby enhance efforts to protect the food supply and work toward ensuring the public's health. The FDACS Division of Food Safety particpates in the Manufactured Food Regulatory Program with sample collection and inspections performed by the Bureau of Food Inspection and testing performed the the FDACS Food Laboratories, who also operates under the Division of Food Safety. Food Laboratories are active participants in multiple Federal Programs including being a FDA FERN CAP lab in both the chemistry and microbiological areas under grant number 1U18FD005506. In addition, the Food Laboratories are a USDA FERN grant participant. The FDACS Food Laboratories currently analyze over 7000 food samples per year with the current sample load including FDA and USDA regulated products and environmental swab samples from food manufacturing facilities. The collection and analysis of an additional 75 or more samples specifically for this project can be accommodated within the existing Inspection's sample collection and Food Laboratories testing programs.